KSHV alteration of cellular metabolism

Kaposi's Sarcoma (KS) is the most common tumor of AIDS patients worldwide and is the most commonly
reported tumor in parts of Africa. The predominant tumor cell is the spindle cell, a cell of endothelial origin.
The etiologic agent of KS is the Kaposi's Sarcoma-associated herpesvirus (KSHV or HHV-8), a gamma
herpesvirus. KSHV is latent in greater than 95% of the spindle cells in the tumor, with a low percentage of
spindle cells supporting lytic replication. Infection of endothelial cells in culture leads to similar percentages of
latent and lytic infection leading us to use cultured endothelial cell infection as a model of infection. We have
demonstrated that KSHV dramatically alters endothelial cell metabolism upon infection including induction of
glycolysis, glutaminolysis and fatty acid synthesis. Interestingly, all of these metabolic pathways are also
induced in tumor cells from a variety of cancers and are required for the survival of cancer cells. Inhibition of
these pathways induces cell death in latently infected cells but not mock infected cells indicating that this is a
potential therapeutic target for intervention. These pathways center around the mitochondria. In preliminary
data we found that mitochondrial translation is necessary for proliferation and survival of latently infected
cells. In this proposal we will determine the role of the mitochondria in KSHV latency and how KSHV directly
alters the mitochondria leading to altered mitochondrial function. We will also examine how KSHV alteration
of mitochondria alters other metabolic pathways in the latently infected cells. These studies will shed light on
how KSHV latent infection of endothelial cells requires alterations in cellular metabolism for survival through
determination of how KSHV alters cellular stress and mitochondria as well as the viral mechanisms involved.
A number of the mitochondrial pathway examined in this proposal are therapeutic targets with FDA approved
drugs and could potentially be used to target KSHV latent infection and ultimately KS tumors.
!

Public health relevance
Narrative: Kaposi's Sarcoma is the most common tumor of AIDS patients worldwide and is caused by the Kaposi's Sarcoma-associated herpesvirus. KSHV is present in the latent state in the KS tumor cells, cells of endothelial origin. Through the study of how cellular metabolic processes are required for KSHV latent infection of endothelial cells, we will identify novel therapeutic targets to inhibit latency and therefore, KS tumors. !